Admin Supp for Longitudinal multimodal mapping to decipher the neurovascular impact of microinfarcts

Project Summary No changes from original grant R01NS109361

Public health relevance
Project Narrative No changes from original grant R01NS109361